Fostering Research Mentorship and Training During Psychiatry Residency

Project Summary/Abstract
There has been a significant decline in the number of research psychiatrists and research fellowships for
psychiatrists in the past decades. To address this gap, it is critically important to provide early research
training in psychiatry residency. Such training (a) promotes research literacy for all trainees, (b) encourages
future participation of clinicians as research collaborators, (c) provides experience that can foster choosing a
research career, (d) expands clinical knowledge through the formulation of patient- oriented research
questions, (e) attracts medical students into psychiatry training, and (f) maintains and facilitates research
interest among residents with investigative backgrounds (IOM 2003). In response to this need, investigators at
the Massachusetts General Hospital (MGH) Department of Psychiatry and McLean Hospital collaborated with
the leadership of the MGH/McLean General Adult Psychiatry Residency to develop a Physician Scientist
Training Program (PSTP) within the residency training program. The goal of the PSTP is to prepare residents
from diverse backgrounds for careers as investigators in academic psychiatry by facilitating greater exposure
to research activities and training during residency. The PSTP has been successful in attracting and recruiting
talented physician-scientists and has developed an effective research education program with appropriate
infrastructure attracting clinician-scientists to psychiatry careers. It has provided them both mentorship and
research experience to prepare for independent careers in psychiatry combined with neuroscience, genetics,
and public health after residency. We wish to further this success in the current application with program goals
to: (1) attract, train, and retain excellent residents to become future psychiatrist-investigators in basic,
translational, and patient-oriented research during the four years of residency training, with an ultimate goal of
retaining physician-scientists for those with formal graduate training and recruiting and developing physician-
scientists for those without it; (2) provide dedicated time and training for research over the course of the four-
year adult psychiatry residency training program; (3) increase the number of residents who benefit from the
research education program; (4) broaden and deepen the research education program by providing greater
and more intensive training in research literacy to all residents in the residency training program; (5) provide
seed funding for pilot research projects designed by PSTP residents; and (6) partner with training programs
within MGH and McLean Hospital as well as Harvard Catalyst, the Clinical and Translational Science Center
(CTSC), and the Broad Institute, so all residents will benefit from these educational resources. The new
specific aims for this application are to (1) strengthen the core PSTP curriculum for trainees with a diverse
range of research interests and levels of formal research training, (2) expand research support to trainees from
underrepresented backgrounds, and (3) establish an iterative process for trainee and program evaluation and
ongoing improvement in a rapidly changing world.

Public health relevance
Project Narrative In 2007, Massachusetts General (MGH) and McLean Hospitals piloted an integrated Research Concentration within the MGH/McLean Adult Psychiatry Residency Program to address the critical shortage of physician- scientists engaged in mental health research careers. This program has been highly successful in its goal of retaining MD/PhD trained physician-scientists and recruiting and developing new physician-scientists. This application will provide support and infrastructure to continue, improve, and expand this well-integrated research education program that serves to attract and train residents to become future psychiatrist-scientists in basic, translational, and patient-oriented research, while increasing research literacy among all residents.